Global Center on Climate Change and Water Energy Food Health Systems - Data Core

DATA SERVICES CORE ABSTRACT
The Data Services Core (DSC) of the proposed Global Center on Climate Change and Water, Energy, Food and
Health (GC3WEFH) will provide data and computational support for the research project team of the GC3WEFH
and for other related center activities, including advanced research addressing research questions, training, and
community engagement. Capacity-building efforts with respect to data collection, data analysis, and visualization
will be designed to help the health research community and NGOs in Jordan in informed decision-making and
to ensure the sustainability and scalability of the model developments achieved during this exploratory phase of
the GC3WEFH. The team assembled has deep expertise in relevant work, access to needed data, and a track
record of achieving research aims of impact on time. To support the GC3WEFH in its overall mission of
addressing climate change health impacts among the most vulnerable global communities, the DSC will focus
on the following specific aims and tasks: 1) Data Hub: Organize available data into a searchable online catalog
of curated datasets with comprehensive metadata and provenance information, ready for analysis of interactions
in the water-food-energy-health (WEFH) nexus in Jordan. 2) Capacity building and training: Build capacity of our
partners in Jordan by developing advanced data management and data science research curriculum materials
on local WEFH themes, particularly data collection, mapping, and spatial analysis and modeling, and delivering
the curriculum through online webinars and in-person workshops in Jordan. 3) Technical assistance to the
Research Project Core: Support Center scientists with technical assistance in data and spatial analyses and
mapping to minimize time from data collection and management to research. 4) Data collection, broad
community engagement, and policy advancement: Collaborate with the Community Engagement Core to
establish the DSC as a resource for additional project stakeholders, including partnering community
organizations, the Ministry of Health, the Higher Council for Science and Technology (HCST), and the Royal
Scientific Society, to translate the collected information and scientific insights into behaviors, policies, and actions
to address climate change health impacts in the Azraq Basin area of Jordan.